DELIVERY OF CELL LINES/DERIVATIVES FOR RESEARCH PURPOSES

The objective of this request is to procure up to an additional 150 cell lines and/or derivatives selected by OCG to be sent to collaborators and grantees as indicated by OCG. https://hcmi-searchable-catalog.nci.nih.gov/ The cell lines and/or derivatives selected will be based on currently available inventory at the time of order.